Myb Regulation of Megakaryocyte Immune Differentiation

Abstract
Recent publications have sparked a renewed interest towards the origin and functions of megakaryocytes
localized to the lung. Our laboratory previously reported that lung and bone marrow megakaryocytes are
morphologically and functionally distinct. Specifically, lung megakaryocytes are lower ploidy and more immune
differentiated than bone marrow megakaryocytes. Despite these differences, however, we recently discovered
that both megakaryocyte populations are derived from hematopoietic progenitors in the bone marrow.
Consequently, we aim to determine the mechanistic determinants associated with differentiation of
heterogenous megakaryocyte populations. My preliminary data identify the transcription factor Myb as a gene
highly expressed in bone marrow, but not lung megakaryocytes. Using transgenic mouse models, I determined
that Myb expressing megakaryocytes have decreased expression of immune markers. Furthermore,
megakaryocyte specific deletion of Myb is associated with more immune differentiated megakaryocytes,
representative of the subpopulation localized to the lung. We hypothesize that Myb limits megakaryocytes
immune differentiation, and therefore regulates the function of lung versus bone marrow derived platelets. We
seek to identify the mechanisms by which Myb regulates megakaryocyte immune differentiation to generate an
expanded model of platelet function and phenotype. We seek to leverage this information to generate
therapeutic strategies to target inflammation associated with cardiovascular disease pathologies.

Public health relevance
Narrative A developmentally distinct population of megakaryocytes migrate from the bone marrow to the lung. Megakaryocytes in the lung have increased expression of immune molecules and phagocytose antigens. The proposed aims will investigate the role of the transcription factor Myb in driving the immune phenotypes of megakaryocytes.